Acute and chronic effects of GLP-1R agonism on NPY/AgRP neuronal activity

Glucagon-like peptide 1 (GLP-1)-based therapeutics have profound effects on body weight and blood glucose management. GLP-1 cells are located in both the periphery and the caudal medulla, specifically within the nucleus tractus solitarius (NTS). However, the effects of GLP-1 or long-acting GLP-1 receptor agonists (GLP1Rags) on synaptic/cellular properties in the brain and their contribution to metabolic changes are not entirely understood. Based on pilot data, we hypothesize that a DMH GLP-1R → NPY/AgRP neuron circuit is a target for brain-derived GLP-1 neurons and GLP-1Rags. Our objective is to determine if DMH GLP-1R neurons are required for the NTS GLP-1-induced effects on NPY/AgRP activity and metabolism. The project will use
chemogenetics, electrophysiology, and in-vivo calcium imaging to investigate these questions. These experiments will potentially bridge our understanding of the regulation and physiological roles of the GLP-1system in the brain and in the treatment of metabolic disease.
Glucagon-like-peptide-1 receptor agonists (GLP-1Rags) have profound anti-diabetic and antiobesity effects, but the neural systems responsible for mediating these effects are not fully understood. The endogenous function of brain-derived GLP-1, located in the Nucleus Tractus Solitarius (NTS), may provide insight into the effects of GLP-1Rags in the brain. In particular, NTS GLP-1 neurons target multiple brain regions and reduce food intake and glucose production upon activation, which is similar to the effects of GLP-1Rags. While NTS GLP-1 neurons do not express GLP-1receptors, GLP-1Rags may activate target nuclei downstream of NTS GLP-1 neurons that do express GLP-1Rs, thereby mimicking the effects of stimulating NTS GLP-1 neurons. We hypothesize one component of the beneficial effects of both NTS GLP-1 and GLP-1Rags on metabolism involves an NTS GLP-1 neuron → dorsal medial nucleus of the hypothalamus (DMH) GABAergic neuron → Arcuate nucleus circuit that ultimately reduces Neuropeptide Y/Agouti-related peptide (NPY/AgRP) neuron activity. This study aims to define this NTS → DMH → arcuate circuit and determine if GLP-1Rags and central GLP-1 converge on the DMH to inhibit NPY/AgRP neurons and improve metabolism. Previous work and preliminary data demonstrate that: 1) GLP1-Rags decrease the excitability of NPY/AgRP neurons, 2) a GABAergic neuron that expresses GLP-1Rs and leptin receptors (LepRs) resides in the DMH, 3) DMH GLP-1R+ and LepR+ neurons are activated by GLP-1Rags, food presentation/intake, and/or elevated glucose levels, and 4) there is synchrony in the regulation of activity of these neurons. Specifically, when NTS GLP-1 or DMH LepR+/GLP-1R+ neurons are activated, NPY/AgRP neurons are inhibited. These findings suggest the NTS GLP-1 → DMH GLP-1R/LepR → NPY/AgRP circuit functions as a convergence point for satiety signals. We aim to investigate the role of DMH GLP-1R+ neurons in mediating the effects of GLP-1Rags and NTS GLP-1 neuron activity, as well as explore how this circuit affects NPY/AgRP neuron activity and metabolism. The proposed model (Figure 1) predicts that activation of DMH GLP-1R neurons by GLP-1Rags or by NTS GLP-1 neuronal projections (e.g. in response to a meal or in response to exercise) leads to increased GABA release from DMH GLP-1R neurons and inhibition of NPY/AgRP activity. This, in turn, mediates various beneficial metabolic effects of central GLP-1 and GLP-1/Rags. The studies outlined below are designed to directly test the predictions.
Specific Aim – To determine if increased activity of NTS GLP-1 neurons alters DMH and arcuate NPY/AgRP neuron physiology and metabolism. We hypothesize that NTS GLP-1 neuron activation leads to inhibition of arcuate NPY/AgRP neurons through a GABAergic DMH interneuron that expresses GLP-1Rs and/or LepRs. We will utilize optogenetic and chemogenetic approaches to activate NTS GLP-1 neurons while simultaneously monitoring DMH GLP-1R+ or LepR+ neurons as well as arcuate NPY/AgRP neuron activity exvivo (electrophysiology) and in-vivo (calcium imaging).
Summary: The proposed studies link the GLP-1R agonist class of anti-obesity/anti-diabetes medications to a novel NTS GLP-1 → DMH GLP-1R/LepR → NPY/AgRP circuit. We will examine the requirement of GLP-1 neurotransmission and GLP-1R signaling in the plasticity of this circuit using patch clamp electrophysiology, invivo calcium imaging, and metabolic phenotyping with unique mouse models already in hand

Public health relevance
The proposed studies aim to investigate the acute and chronic effects of GLP-1 on neural circuits and the overlap with GLP-1R agonists to improve metabolism. This research has important clinical implications as GLP-1 receptor agonists are exceedingly common therapeutics in diabetes treatment and chronic weight management.